CORE--ETIOLOGIC STUDIES OF GASTRIC CARCINOMA

The core A of this Program Project is based in the Section of Epidemiology, Department of Pathology, LSUMC. It provides the following main functions. 1. Scientific Coordination. To maintain communication and flow of information between all scientists involved int he individual projects. 2. Administration. To carry out the multiple chores needed to allow the different projects to function properly, such as manage personnel, purchases, local accounting, shipping of samples, manuscripts for publications, progress reports, etc. 3. Data Management. To receive the data supplied by each project, conduct data entry as needed, develop and implement programs, maintain and update the individual data files, and manage the tissue and serum bank.